Core A: Administrative Core

Abstract
The UNC Breast Cancer SPORE Administrative Core has supported the infrastructure, planning, and
evaluation of the UNC Breast SPORE since 1992. The Administrative Core and its leaders Earp, Perou, and
Carey are responsible for the institutional long-range plans and resource commitments of the Cancer Center’s
largest translational portfolio.
The functions of the Administrative Core include organizing weekly leadership meetings, monthly SPORE
faculty scientific meeting, quarterly Executive Committee and Advocate meetings and the yearly External
Advisory Board. The Core collates formal reports to evaluate the progress of all SPORE elements, projects,
pilots and career development and mentorship. The Core facilitates interactions with the NCI SPORE program
and other NCI SPOREs, as well as multiple breast cancer research collaborations both nationally and
internationally. The Core manages the Career Enhancement Program, including conducting external and
internal searches for talented potential SPORE investigators; and the Developmental Research Program,
including organizing the pilot project competition and facilitating funding and evaluation of DRP projects. The
Core follows the accrual to clinical trials and the data on the breast cancer care population including minority
accrual. The Administrative Core manages the finances of the SPORE including the substantial institutional
commitment to projects, infrastructure and recruitment allocated to leadership, approaching $8M over the last
five years as well as the $7-8M commitment for the proposed 5-year renewal. The Core implements the results
of evaluations.
Through these activities, the UNC Breast SPORE Administrative Core supports an exceptional team of breast
cancer translational researchers as they explore and address minority disparities research, genomic analysis,
molecular subtyping and therapeutic resistance, while advancing new technology and developing junior faculty
into translational research leaders.

Public health relevance
Project Narrative The Administration Core supports the four projects and core resources that will continue to explore and address minority disparities research, inflammatory signaling, molecular subtyping and therapeutic resistance, while advancing new technology and developing junior faculty into translational research leaders.